Therapeutic efficacies of neutrophil elastase and RIP1 inhibitors in acute lung injury

5. Project Summary/Abstract
Acute lung injury (ALI) is a syndrome of respiratory failure characterized by protein-rich pulmonary edema that
causes severe hypoxemia and labored breathing. In the United States, the annual incidence of ALI is about
200,000 with a mortality rate of 30-40%; yet, there is no FDA-approved pharmacological therapy for ALI.
Neutrophils are the most abundant circulating white blood cells in the human body and provide the first line of
defense against invading pathogens. In the lung, while neutrophils are essential for pathogen elimination,
exuberant accumulation and prolonged survival of neutrophils in the interstitial and alveolar spaces contribute
to ALI by releasing a variety of injurious molecules, including neutrophil elastase (NE), metalloproteases,
reactive oxygen species (ROS), and other proteolytic enzymes. Although all these injurious molecules
contribute to ALI, an increasing body of studies have demonstrated that NE is the most potent hydrolytic
enzyme that plays a key role in lung alveolar injury, and that inhibition of NE with small molecular inhibitors
[e.g. Sivelestat (Siv)] reduces measures of lung injury and inflammation in animal models of ALI. However,
clinical studies have not yet provided a clear consensus. Whereas in Japanese phase III clinical trials, Siv
improved pulmonary functions, in North American multicenter studies, Siv rather increased long-term mortality
by unknown mechanisms. Thus, identification of molecular events associated with adverse effects of Siv in ALI
is an important task for the development of novel and combination treatment regimens. Recently, in unbiased
functional protease purification experiments, we discovered that NE cleaves receptor interacting protein 1
(RIP1), and that inhibition of NE with Siv leads to RIP1-dependent necroptosis in mouse and human
neutrophils following treatment with lipopolysaccharide (LPS) or TNFα. Such RIP1-induced necroptosis can be
inhibited by RIP1 kinase inhibitors (e.g. Nec-1s) or knockout (KO) of RIP3. We found that LPS/Siv-induced
necroptosis was significantly inhibited in RIP3 KO neutrophils. Importantly, in a mouse model of ALI induced by
50% lethal dose of LPS, Siv in combination with Nec-1s resulted in 90% survival of the mice (P=0.001),
whereas neither Siv nor Nec-1s alone afforded significant protection against the death. Thus, we hypothesize
that inhibition of NE with Siv in ALI leads to RIP1-mediated necroptosis in neutrophils, which causes secondary
inflammation and lung injury, and that inhibition of RIP1-mediated necroptosis significantly improves the
effectiveness of NE inhibitors in ALI. Aim-1. Determine the therapeutic efficacies of RIP1 and NE inhibitors in
lung injury and inflammation using mouse models of ALI. Aim-2. Determine how genetic ablation of NE or RIP3
affects lung injury and inflammation in ALI mice.

Public health relevance
6. Project Narrative The goals of this proposal are to define the molecular mechanisms by which neutrophil elastase (NE) regulates RIP1 protein abundance in neutrophils, and to evaluate the therapeutic efficacy of combined inhibition of NE and RIP1 in LPS- and bacteria-induced mouse models of acute lung injury.